Development of Systems and Education for Cervical Cancer prevention (DOSE-CC)

PROJECT SUMMARY / ABSTRACT
Cervical cancer disproportionately affects Black, Hispanic, and low-income Americans. Universal screening
has the potential to decrease the overall burden of cervical cancer and to reduce racial and ethnic disparities in
this disease. However, more than half of the individuals who develop cervical cancer have not been screened
in more than 5 years, and 20% did not follow-up after an abnormal result. To address this problem, we aim to
adapt and test an intervention to improve cervical screening and follow-up in three diverse, underserved
populations: urban inner city Blacks/Haitians (Boston), Hispanic immigrants (Florida), and Hawaiian
Natives/Pacific Islanders (Hawaii). Our research group previously developed a successful intervention to
improve HPV vaccination rates, which we plan to adapt for cervical cancer screening. The intervention
combines education and quality improvement methods using a mechanism called Performance Improvement
Continuing Medical Education. This type of intervention is attractive to clinicians because they are able to
improve their cancer prevention practices while fulfilling requirements for maintaining board certification. When
applied to HPV vaccination, the intervention improved rates by over 10 percentage points, and gains continued
for over 4 years after the intervention concluded. The goal of the proposed research is to adapt the intervention
to cervical cancer screening, and to evaluate its effectiveness in improving screening and follow-up after
abnormal results. First, we will adapt our successful HPV vaccine intervention to address cervical cancer
screening (DOSE-CC). We will interview key stakeholders to explore facilitators and barriers to screening and
follow-up at the patient, clinician, and healthcare setting levels and use these findings and Advisory Board
input to develop the DOSE-CC intervention. Second, we will validate DOSE-CC using a Hybrid Type 1
effectiveness-implementation, stepped-wedge randomized controlled trial design of the 6-month intervention,
reaching over 40,000 patients. Third, guided by the RE-AIM QuEST framework, we will conduct semi-
structured interviews of key stakeholders to examine intervention reach, adoption, implementation,
maintenance and sustainability, and barriers and facilitators of intervention success. The proposed intervention
represents an innovative and scalable model for promoting cancer prevention and screening activities by
clinicians. Unlike programs that increase administrative burdens on busy clinicians, the proposed intervention
allows clinicians to improve cancer prevention practices while simultaneously fulfilling requirements to maintain
their board certification and improving the quality of cancer prevention care. It therefore has great potential for
widespread dissemination.

Public health relevance
PROJECT NARRATIVE Many people who develop cervical cancer have either not participated in screening or not followed up after an abnormal result. In this project, we will adapt and implement an intervention with patients, clinicians, and health systems to improve rates of cervical cancer screening and follow-up after an abnormal result to ensure patients receive the follow up and treatment they need to prevent cancer.